Hyperstable FGF1-FGF2 based therapeutic formulation for wound care

PROJECT SUMMARY
Chronic wounds are a serious problem that affects the health and quality of life of patients with diabetes and
cardiovascular diseases. These non-healing ulcers are characterized by prolonged inflammation, poor
vascularization, callus formation, and infection. Advanced wound care is estimated to cost over $10 Billion
annually in the U.S. and is expected to increase as our population ages. A variety of advanced wound care
products have been developed to deliver cellular growth factors, particularly fibroblast growth factors (FGFs), to
the wound site to treat debilitating non-healing ulcers. However, poor efficacy has frequently been reported in
clinical studies involving FGF delivery to wounds due to the following major obstacles: 1) the poor stability and
proteolytic susceptibility of growth factors in vivo, 2) the difficulty of providing a controlled and sustained delivery
of the growth factors, and 3) a lack of biomarkers to evaluate efficacy and to guide the development of new
therapies. The overall objective of the proposal is to address these challenges through an integrative effort to
develop a hyperstable and bioactive wt-FGF1-FGF2 dimer for effective healing of diabetic skin wounds. The
efficacy of this new therapeutic approach will be monitored by quantitative in vivo metabolic imaging.
The overall objective of this proposal is achieved by: 1) designing of a hyperstable and bioactive FGF1-FGF2
dimer and its hyperstable variants; 2) developing the injectable anionic hydrogels made of gelatin-modified
poly(oligo ethylene glycol monoacrylate-co-acrylic acid) – P(OEGA-co-AA), which can provide sustained release
of the different variants of the FGF1-FGF2 dimer; and, 3) to monitor metabolic of wt-FGF1-FGF2 dimer and its
hyperstable variants using simultaneous acquisition of multiphoton images of NADH and FAD auto fluorescence,
as well as collagen SHG intensity. Further, non-invasive Diffuse Reflectance Spectroscopy (DRS) will be used
to evaluate angiogenesis activity, plausibly triggered by the FGF2 component of the designed FGF1-FGF2 dimer
and its variants.

Public health relevance
PROJECT NARRATIVE Chronic skin wounds are a serious problem that affect the health and quality of life of millions of Americans and create a significant financial burden on the entire health care system. Growth factors are small signaling proteins that can in principle stimulate tissue repair, but rapidly lose their bioactivity and show poor clinical efficacy. Hyper- stable growth factors and a hydrogel wound dressing to be developed and validated here will enable sustained release of persistent growth factors and a protective environment for improved healing of chronic wounds.